MOSAIC: Administrative Core

SUMMARY: ADMINISTRATIVE CORE
The overarching objective for the Mayo/Columbia MOSAIC CSBC is to build a conceptual framework to
understand tissue state transitions that happen in glioma and the ways to interpret magnetic resonance imaging
(MRI) relative to those changes for these key cellular phenotypes. Achieving this objective will require a multi-
faceted approach reflected by the multiple projects and cores being proposed. The administrative core will be
the primary touchpoint for all pieces of the proposal, overseeing that work is done in an efficient way and
providing the necessary administrative support to coordinate all efforts. The central work for our CSBC revolves
around extensive analysis of image-localized biopsies that are collected, processed, and stored by Biospecimen
Core, analyzed by the Data Integration and Computation Core, and shared between Projects 1 and 2. This
highly integrated analysis of image-localized biopsies from GBM patients with clinical imaging will be actively
managed by the Administrative Core to ensure a smooth experimental flow with an emphasis on quality and
reproducibility.
We envision that MOSAIC will serve as a nexus for collaborations focused on the topics revolving around tissue
state transitions and clinical imaging across the consortium with likely areas of interest in other cancers beyond
glioma. A key function of the Administrative Core will be to actively cultivate such collaborations through
coordination with our Outreach Core, particularly through administering Intra-Center and Cross-Consortium Pilot
Projects, hosting workshops and symposiums, and facilitating visiting faculty all while enhancing diverse
perspectives on this critical topic. These activities will extend both to collaborations between institutions involved
in the Mayo/Columbia CSBC and collaborations across the U54 and U01 holders within the CSBC and PSON
networks.
In the Administrative Core, our aims—to manage center logistics and communication, administer Intra-Center
Pilot Projects, and create and support the External Advisory Committee—will support all aspects of our
application. Co-PDs Swanson and Canoll will provide the central leadership in the Administrative Core, while
the Center Program Administrator will provide day-to-day business, administrative and scientific management of
Center activities.

Public health relevance
NARRATIVE: ADMINISTRATIVE CORE The Administrative Core will be the primary touchpoint of the center, facilitating interactions between the two projects and three additional cores. The Administrative Core will also actively cultivate collaborations throughout the consortium with assistance from the Outreach Core, particularly through administering Intra-Center and Cross-Consortium Pilot Projects, hosting workshops and symposiums, and facilitating visiting faculty all while enhancing diverse perspectives on this critical topic. Co-PDs Swanson and Canoll will provide the central leadership in the Administrative Core, while the Center Program Administrator will provide day-to-day business, administrative and scientific management of Center activities.